Cellular and Molecular Mechanisms of Atrial Cardiomyocyte Lineage Commitment

Project Summary The purpose of this five-year proposal is to provide an integrative and personalized training program for the applicant to transition into an independent academic position as a basic scientist in cardiac development and regeneration. The long-term goal is to understand the underlying mechanisms of atrial CM lineage development and atria-related congenitial heart diseases. The applicant has a strong background in single-cell gene expression analysis, tissue cell culture, and mouse embryonic development with facility at the bench in all aspects of single-cell analysis, tissue cell culture, and mouse embryos dissection. This career development plan (K99 phase) will provide additional training in embryonic histology analysis, ChIP-seq data analysis, and cardiac phenotypic analysis of transgenic mouse embryos to investigate the mechanisms of RA signaling in promoting atrial CM lineage development. The applicant will also receive a wealth of informal and didactic training at Stanford University in specialized areas such as professional development and writing skills, which will be critical for the applicant to gain autonomy and launch a productive career as an independent investigator. Under the expert mentorship of Dr. Sean Wu, MD PhD along with the assembled advisory committee (Dr. Quertermous, Dr. Ruiz-Lozano, Dr. Krasnow, Dr. Bernstein, and Dr. Martin), the applicant will receive the necessary guidance and resources to accomplish these goals and efficiently transition to independence during the R00 phase. Atrial CM lineage development is a basic cellular process, and retinoic acid (RA) signaling has been reported to be a critical pathway in promoting this process, but the underlying cellular and molecular mechanisms are still largely unclear. The applicant has developed a single cell progeny assay to analyze the lineage specification of cardiac progenitor cells, and identified a list of highly promising atrial CM specific genes with single cell RNA sequencing. In this proposal, he will use conditional knockout mice, single-cell progeny assay, RA signaling report assay, gene overexpression or downregulation assay, and ChIP-seq technology to analyze the cellular and molecular mechanisms of RA signaling in promoting atrial CM lineage development. Results from this research are expected to provide insights into the mechanisms of atrial tissue-related congenital heart diseases. His specific aims are: Aim 1 (K99): To define the cellular mechanisms of RA signaling in promoting atrial CM lineage development. Aim 2 (R00): To define the molecular mechanisms of RA signaling in promoting atrial CM lineage development.

Public health relevance
Application Title: Cellular and molecular mechanisms of atrial cardiomyocyte lineage commitment Project Narrative Congenital heart disease accounts for a significant proportion of stillbirths and is present in 1- 2% of all live births. Understanding the cellular and molecular mechanisms of atrial CM lineage commitment is crucial towards developing more accurate diagnoses and devising better treatments for congenital heart diseases such as Ebstein’s anomaly and atrial septal defect. Thus the proposed work is relevant to the mission of the NIH, which is “relating the causes, diagnosis, prevention, and cure of human disease” by increasing our fundamental knowledge of congenital heart malformations to reduce the burdens of complex human disease.